IGF::OT::IGF Mobile App to Improve Medication Adherence in Adults with Prescripti

The Contractor will develop and validate mobile phone-based interventions to improve prescription medication adherence based on each patient's individual preferences and traits.